Characterizing the Plasmodium falciparum Apicomplexan amino acid transporter 2 and its proline transport capability

PROJECT SUMMARY
Malaria remains one of the leading causes of death worldwide and affects about half the global population,
despite decades of public health efforts. Plasmodium falciparum, the parasitic agent responsible for malaria,
undergoes a complex life cycle involving intracellular parasitism in the human host and extracellular development
in the mosquito vector. We have previously shown that resistance to halofuginone (HFG), a potent antimalarial
that targets the P. falciparum cytoplasmic prolyl tRNA synthetase (PfcProRS), can be achieved by the parasite
through two different mechanisms: mutation in the target gene or an increase in intracellular proline, which
competes with binding of HFG to PfcProRS. We have recently discovered that the increase in proline is due to
loss of function mutations in the Apicomplexan Amino acid Transporter 2 (PfApiAT2). Parasites with premature
stop codons obtained by selection with HFG or a knockout (KO) of PfApiAT2 have a up to 20-fold increase in
cellular proline compared to the parental line. These KO parasites do not have a growth phenotype in the blood
stages of the parasite but our preliminary data as well as published data in P. berghei suggests that ApiAT2 is
essential in the mosquito stages. While blood stage parasites obtain the majority of their amino acid needs from
parasite specific hemoglobin digestion, mosquito stage parasites are extracellular and need to take up all their
nutrients form the hemolymph on the mosquito. The molecular mechanisms for this, however, remain largely
unexplored.
Our central hypothesis is that PfApiAT2 is a proline transporter which transports excess proline out of
the parasite in the blood stages and imports proline into the parasite from the hemolymph in the
mosquito stages. We will test this hypothesis by characterizing the proline transport capacity of PfApiAT2 in
the heterologous expression system of Xenopus laevis oocytes as well as in P. falciparum parasites directly
using radiolabeled proline. To better understand the biological function of PfApiAT2, we will generate KO
parasites and determine their exact time of arrest in the mosquito. In addition, we will use the novel technology
of ultrastructure expansion microscopy to gain high-resolution localization of PfApiAT2 in the mosquito stages.
Our specific aims are as follows:
Aim 1. Determine the proline transport capability of PfApiAT2
Aim 2 Assess the function and localization of PfApiAT2 in the mosquito stages of P. falciparum

Public health relevance
PROJECT NARRATIVE Membrane transport proteins play an important role in resistance to anti-malarial drugs but are also crucial for providing nutrients through the complex lifecycle of the malaria parasite Plasmodium falciparum. We recently discovered that loss-of-function mutations in the P. falciparum Apicomplexan amino Acid Transporter 2 (PfApiAT2) confer resistance to Halofuginone via increased intracellular proline, which competes with Halofuginone for binding to its target. Here, we will examine the role of PfApiAT2 in proline transport using the heterologous Xenopus laevis expression system and solute-flux assays in P. falciparum parasites, and assess the essentiality of PfApiAT2 in the mosquito transmission stages in which parasite nutrient acquisition is poorly understood.